Training Program in Metabolic Biology

Project Summary/Abstract
The UC Berkeley/UCSF joint Training Program in Metabolic Biology (TPMB) offers unique opportunities for
trainees to gain a strong foundation in rigorous, reproducible science, and to acquire the professional skills
and knowledge to support future leaders in the field of human metabolic health and disease research. Built
around an inter-departmental, trans-institutional training program, it brings together world-leading researchers
and mentors from UCB's Department of Nutritional Sciences and Toxicology (NST) and UCSF's Diabetes
Center (DC) to offer an unparalleled training experience for predoctoral fellows. TPMB seeks to attract a
diverse group of highly qualified students from various academic backgrounds including biochemistry, cell and
molecular biology, nutrition, and physiology. Our curriculum is build around development of scholarship and
skills in research, teaching and professional service with the goals of establishing early research
independence and laying a foundation for research integrity and responsibility. In addition to taking TPMB
specific courses that emphasize human health and disease topics in metabolic regulation, research design
and reproducibility, data analysis and interpretation, as well as ethical conduct, students will be able to rotate
through laboratories both on the UCB and UCSF Parnassus campuses in their first year. TPMB students will
experience a nurturing, diverse, and exciting environment that has build a well-established and integrated
community of program leadership, researchers and preceptors across the two campuses and is well aware of
the opportunities and potential challenges this approach offers. In order to make informed choices for their
rotations incoming students will be exposed to the variety of metabolism centered research in the program
through introductory lectures given by all TPMB faculty and participate in the programs joint annual retreat
offering talks, posters, and social interactions with faculty, students, and postdocs. A central strength of TPMB
is the quality of our faculty and the breath of human health and metabolism focused research topics ranging
from central regulation of feeding behavior to adipocyte biology and ß-cells and state-of-the-art technical
approaches from single-cell-sequencing, to metabolomics, genetics, stem cell biology, and bioengineering
and the ability to pursue research in both clinical and preclinical settings. This wide range of expertise and
approaches foster collaborative science and prepare TPMB students to successfully transition into
independent careers in academia, industry, and government to tackle problems central to the mission of
NIDDK and to improve human health and wellbeing.

Public health relevance
Project Narrative Dysregulated metabolism and obesity-associated diseases, particularly diabetes, have reached epidemic proportions world-wide. There is growing need to train scientists who meld the entire “tool chest” of biological techniques to study the regulation of metabolism as it relates to human disease risk on the on all levels ranging from humans, to animal models, and cellular and molecular mechanisms. This inter-departmental, trans- institutional training program in Metabolic Biology unites faculty at the University of California-Berkeley in the Department of Nutritional Sciences and Toxicology (UCB-NST) and the University of California-San Francisco Diabetes Center (UCSF-DC) to train scientists capable to generate insight into mechanisms of disease and disease risk related to intermediary metabolism and metabolic regulation.